Path C The State of Utah Cooperative Agreement to Implement and Enhance a Produce Safety Program

PAR 21-174 Utah
Project Summary
The UDAF Produce Safety Program is applying for path C under PAR 21-174, with the authority to
conduct Produce Safety Inspections under State Statute where 21 CFR 112 has been adopted by
reference:
https://le.utah.gov/xcode/Title4/Chapter5/4-5-S104.html?v=C4-5-S104_2017050920170701
The Utah Produce Safety Program will continue to conduct a Jurisdictional Self-Assessment and track
performance measures in conjunction with development and modifications of the Project Outline and
Strategic Plan for all objectives listed in the FOA and report sharing under a 20.88 agreement.
The Utah Produce Safety Program will maintain the program and required reporting with the CAP. We
will identify training needs and develop a succession plan. We will continue our working relationship
with NASDA, FDA, and other States. We plan to continue to have our Program Administration attend the
Annual Produce Safety Consortium.
UDAF will provide education and outreach to all non-exempt covered farms subject to the Produce
Safety Rule; and to also provide education to all other produce growers. UDAF and USU Extension will
continue with outreach and education activities such as PSA Grower Training, OFRR’s, Grower
Associations, Farm visits, UDAF Produce website etc. We will continue with our plans to provide our
farmers with educational resources which have already been developed.
UDAF will continue to manage and maintain their current Utah Produce Farm List. The farm information
will be verified in accordance with our written SOP for Farm Inventory and Farm Verification. Our Farm
Inventory verification goals will be set in line with the FOA for Covered Farms, Qualified Exempt Farms,
Micro Exempt Farms and Process Exempt farms.
The Utah Produce Safety Inspection Program will conduct inspections according to “The Standardized
Approach to Produce Farm Inspections.” Our program will implement and annual inspection work plan
and execute a produce safety inspection calibration program, in coordination with FDA. UDAF Produce
Safety Program and Inspection staff have State legislative authority in regards to Compliance and
Enforcement. The UDAF Produce Safety Compliance and Enforcement will include a risk-based process
to determine when a directed investigation, follow-up or reinspection is needed; UDAF has a framework
for compliance and enforcement progressive actions.
UDAF will have the capability to systematically detect, investigate, mitigate, document and analyze
produce related incidents to stop, control and prevent hazards that are likely to result in a produce
related illness, injury or outbreak. The UDAF Produce Safety Program is currently participating in the
Utah Rapid Response Team Activities.

Public health relevance
PAR-21-174 Utah Project Narrative The Utah Produce Safety Program will educate and enforce the safe production of fresh fruits and vegetables and promote understanding and compliance with the requirements of FDA’s Produce Safety Rule, 21 CFR 112, Standards for the Growing, Harvesting, Packing, and Holding of Produce for Human Consumption. UDAF Regulatory Services, Plant Industry and Utah State University Cooperative Extension have been engaged in working together to implement the Utah Produce Safety Program. This program will cover these objectives: • Self-Assessment and Strategic Planning • Program Administration • Education, Outreach and Technical Assistance • Farm Inventory • Inspection Program • Compliance and Enforcement • Produce Related Event Response Planning and Implementation We will conduct an annual self-assessment and set goals for each FOA objective in our Strategic Plan and Project Outline. The UDAF Produce Safety Program will continue to monitor our Program Administration as needed to be successful in each objective listed above and develop a plan of succession. We will continue to monitor and report on Project Outline goals for Outreach and Education, Farm Inventory, Inspection Program elements, Compliance and Enforcement and Produce Related Event Response Planning and Implementation.